Toxicology Study of Human Complement Factor H Antibody GT103 in Mice Period of Performance 12/19/2018 - 12/18/2019

This task order is to conduct a GLP safety study of Human Complement H Antibody GT103 in mice.